Immune-based therapy against STEC intoxication and HUS

Title: Immune-based therapy against STEC intoxication and HUS
Shiga toxin (Stx) producing E. coli (STEC) are the bacteria responsible for outbreaks and sporadic acute cases
of diarrhea in humans, primarily children, that can lead to hemolytic uremic syndrome (HUS) resulting in acute
kidney failure and CNS abnormalities. No therapy currently exists, and antibiotics are contraindicated. We, and
others, have shown that human monoclonal antibodies (HuMab) against Shiga toxins (Stx1 and Stx2) were
protective in animal models and safe demonstrating that these toxins indeed are the primary cause of STEC
associated HUS, and that specific HuMab is an effective immune-based therapy. However, such treatment is
costly and cumbersome with limited shelf-life and requires intravenous administration to patients at risk of
developing HUS. Here we propose a much-simplified strategy using camelid-derived (VHH) antibodies delivered
by mRNA nanoparticles to prevent or arrest development of HUS. It is expected to be a low-cost and safe
therapy, given in a single intramuscular (IM) injection to patients exposed to or presenting with STEC infection
or bloody diarrhea. The antitoxin product is based on a highly innovative VHH-based neutralizing agents (VNA)
platform developed at our laboratory. Linking VHHs together into VNAs leads to enhanced toxin neutralization
potency and permits the targeting of multiple toxins with a single agent. Such VNAs have now been successfully
generated and tested for efficacy in animal models against botulinum neurotoxin, Clostridium difficile TcdA and
TcdB, ricin, anthrax, and Stx1 and Stx2 toxins. A single VNA protein targeting both Stx1 and Stx2 (VNA-Stx),
injected IP or IM, potently neutralized both Stx1 and Stx2. We previously reported data showing that: a) multiple
IP or IM administrations of VNA-Stx protein protected STEC-infected piglets with diarrhea from developing
systemic intoxication, and; b) a single IM injection of an adenovirus (Ad) vector with a secretory VNA-Stx1/Stx2
transgene was equally protective when given to infected piglets [2]. More recently, we developed a
heterotetrameric VNA that more broadly neutralizes diverse Stx2 natural variants that cause human disease.
Here we propose to complete development of a VNA capable of potent neutralization of all known STEC human
pathogens, and explore and evaluate more practical, simplified VNA delivery systems using various mRNA
delivery technologies (Aim 1). Our hypothesis is that the application of mRNA technology to express a single,
multi-specific VNA will be more effective than HuMab, simpler to manufacture at a fraction of the cost of HuMab
and permit the much more practical intramuscular administration. This hypothesis will be first tested in mice
against toxicosis (Aim 2) and against oral infection of STEC in the gnotobiotic (GB) piglet model. This model
leads to symptoms of acute diarrhea and serious colonic mucosal damage followed ~48 hours later with systemic
vascular-mediated intoxication (fatal neurologic symptoms) that closely mimic some of the sequence of events
observed in humans infected with STEC strains who go on to develop HUS (Aim 3).

Public health relevance
Narrative: Enterohemorrhagic E. coli is a serious cause of food and waterborne diarrhea in humans, and in some cases the infection can lead to kidney failure particularly in children under the age of 5, and in some adults, which can be fatal. There is no prevention or treatment against this disease and this proposal offers to rectify this.